STUDYING HTT PROTEIN AGGREGATION IN CELLS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Imaging the Htt protein aggregation in different cells (COS7, PC12). Studying the different aggregation varying lengths of polyglutamine in the protein. Analyze the dynamics of the process of aggregation.